Engineering MicroEnvironment Core (EMEC)

PROJECT SUMMARY – Core C
New pre-clinical models of both the airway and gastrointestinal epithelium, especially those that adequately
reflect relevant human 3D physiology and disease pathophysiology, are desperately needed to elucidate disease
mechanisms and identify avenues for treatment. The overall objective of the Engineering MicroEnvironment
Core (EMEC) is to provide the group of Biomimetic Collaborative Research Center (BCRC) investigators with
biomaterial and fluidic chamber platforms and additional enabling technologies to improve human
gastrointestinal and lung systems for the studies proposed in Projects 1-3 and the Human Biomimetic Scientific
Core (HBSC, Core B). These biomimetic systems are designed to replicate key aspects of the epithelial cells’
3D physiological and physical environment. These platforms will utilize the biomaterial and tissue engineering
technologies that we established during our original NAMSED funding, and will also build upon these
technologies to expand our capabilities to answer questions about the role of the host mucus layer, cell physical
microenvironment, and cell communities in intestinal and lung infections. The service component of the EMEC
will be to provide engineering tools, including (1) preparing “TransWell Trough” systems to apply flow to co-
cultures of anatomically-distinct epithelial cells, (2) fabricating tissue engineering/biomaterial platforms to support
intestinal or lung epithelial cell cultures, (3) fabricating millifluidic perfusion chambers (mPC) for flow across
intestinal epithelial cells ± pathogens, (4) fabricating and maintaining calibrated stocks of oxygen-sensing
hydrogel-based microparticles, (5) 3D printing of molds and other components of the culture systems being
fabricated, (6) quantifying tissue and biofluid mechanical behavior to prepare in vitro models with physiologically
faithful material properties, (7) computational modeling of fluid dynamics and oxygen transport in culture
systems, and (8) transferring technology through training group members and personnel at other funded U19s.
The development component of EMEC will enhance the previously tested culture systems to mimic the
complexity of the 3D host environment in the proposed studies, through (1) developing a modification of the
TransWell Trough model with dual flow, (2) modifying the hydrogels to enable 3D encapsulation of immune and
neural cells for co-culture studies, (3) developing a modified mPC system to grow the epithelial cells atop a
biomimetic hydrogel surface, and (4) developing customized mucosal mimics to facilitate screening of host
mucus-pathogen interactions. Providing these platforms, tools, and services through a central core will save
time, effort, and costs, accelerate the rate of discovery, and enable comparison of results across Projects
whenever possible. The EMEC will be consultative and responsive to needs of the individual Projects, which
may change as the research proceeds and as the overall field evolves. New activities will be developed to meet
the needs of the Project investigators. Our goal is complementary and collaborative in these efforts to develop
biomimetic engineering models to study the role of the host mucosal surface in enteric and respiratory infections.